MOUSE MODELS OF INSULIN RESISTANCE

DESCRIPTION (provided by applicant): Insulin resistance stands as a significant threat to public health worldwide, and a largely unmet medical need. To unravel the complex biology of this protean syndrome, we have endeavored to apply genetic techniques to probe gene function and tissue interactions related to metabolism, and identify tractable targets for pharmacological intervention in type 2 diabetes. Over the past five years, the notable contributions of this grant to our knowledge of the insulin resistance syndrome have been: (i) a critical reassessment of the relative roles of insulin- dependent and -independent mechanisms of glucose disposal in metabolic homeostasis; (ii) the discovery of mechanisms by which non-canonical sites of insulin action, such as central nervous system (CNS) and endocrine pancreas, play an early and decisive role in the progression from insulin resistance to diabetes; and (iii) the notion that pancreatic beta cells are an insulin-sensitive cell type. Building on these lessons, the PI proposes studies of the integrated physiology of insulin action that will focus primarily on the contribution of CNS, liver and enteroendocrine system to the insulin-resistant state. The PI presents data putatively identifying an insulin-sensitive neuron population, characterized by Glut4 expression; as well as a novel gut epithelial progenitor cell with the unique ability to give rise to bona fide insulin-secreting, Beta-like endocrine cells in vivo. Three aims are outlined: Aim 1 will tackle the role of insulin signaling in brain glucose metabolism, using a novel approach to identify Glut4-expressing neurons and characterize their contribution to systemic metabolism. Aim 2 will delve into the pathophysiology of hepatic insulin resistance, and specifically into the identification of transcription factors that cause the paradoxical admixture of increased glucose production and triglyceride synthesis that characterizes the diabetic liver. Aim 3 will study the role of insulin signaling in a newly identified sub-population of gut epithelial progenitor cells that express the insulin-regulated transcription factor Foxo1 and show the surprising ability to be reprogrammed into Beta-like cells that secrete insulin in response to glucose. The proposed body of work will advance our understanding of the insulin-resistant syndrome at the biochemical, genetic, and integrated physiological levels, with the ultimate goal of translating newly acquired information into innovative approaches to its treatment.

Public health relevance
PUBLIC HEALTH RELEVANCE: In the last decade, we endeavored to unravel the 'insulin code'-a concerted succession of biochemical and cell biological events that underlie the integrated physiology of insulin action. We documented the contribution of Insulin Receptor, its main substrates and signaling intermediates to the key abnormalities of insulin resistance: decreased glucose disposal, increased glucose production, and impaired pancreatic beta cell function. We used genetic techniques to probe hormonal and nutritional communication among different tissues, and analyze the progression from insulin resistance to overt diabetes. We demonstrated how tissues with insulin-dependent glucose disposal (muscle and fat) interact with those that utilize glucose independent of insulin (liver, brain, pancreatic islets) to determine various aspects of insulin resistance. We developed a theory integrating 2 cell function with insulin resistance; and delved into the pathophysiology of the brain's contribution to glucose homeostasis. We also examined the bimodal involvement of the liver in diabetes as a site of mixed sensitivity and resistance to insulin. In the process, we burrowed into the Foxo1 pathway, demonstrating the central position of this transcription factor in the regulation of hepatic glucose production and neuropeptide processing. Reversal of insulin resistance remains a critical goal of diabetes treatment, and arguably one of the largest unmet medical needs. Work supported by this grant has defined mechanisms that we believe to be new, linking insulin action in specific organs and cell types with the pathophysiology of insulin resistance, and disclosing biochemical and molecular circuits that can be exploited for diabetes treatment. We envision that the studies proposed for the next funding cycle will reveal new dimensions to the insulin resistance syndrome and expand the repertoire of currently available targets for diabetes therapy and prevention. The proposed experiments build on lessons of the past funding cycle to explore the contribution of newly identified mechanisms to metabolic homeostasis. The driving theme of our work is to define molecular pathways that can be enlisted in the clinic against insulin resistance. In the last decade, we endeavored to unravel the 'insulin code'-a concerted succession of biochemical and cell biological events that underlie the integrated physiology of insulin action. We documented the contribution of Insulin Receptor, its main substrates and signaling intermediates to the key abnormalities of insulin resistance: decreased glucose disposal, increased glucose production, and impaired pancreatic beta cell function. We used genetic techniques to probe hormonal and nutritional communication among different tissues, and analyze the progression from insulin resistance to overt diabetes. We demonstrated how tissues with insulin-dependent glucose disposal (muscle and fat) interact with those that utilize glucose independent of insulin (liver, brain, pancreatic islets) to determine various aspects of insulin resistance. We developed a theory integrating β cell function with insulin resistance; and delved into the pathophysiology of the brain's contribution to glucose homeostasis. We also examined the bimodal involvement of the liver in diabetes as a site of mixed sensitivity and resistance to insulin. In the process, we burrowed into the Foxo1 pathway, demonstrating the central position of this transcription factor in the regulation of hepatic glucose production and neuropeptide processing. Reversal of insulin resistance remains a critical goal of diabetes treatment, and arguably one of the largest unmet medical needs. Work supported by this grant has defined mechanisms that we believe to be new, linking insulin action in specific organs and cell types with the pathophysiology of insulin resistance, and disclosing biochemical and molecular circuits that can be exploited for diabetes treatment. We envision that the studies proposed for the next funding cycle will reveal new dimensions to the insulin resistance syndrome and expand the repertoire of currently available targets for diabetes therapy and prevention. The proposed experiments build on lessons of the past funding cycle to explore the contribution of newly identified mechanisms to metabolic homeostasis. The driving theme of our work is to define molecular pathways that can be enlisted in the clinic against insulin resistance. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS1 Insulin resistance and β cell failure play key roles in the pathogenesis of type 2 diabetes. Targeted mutagenesis in mice has suggested that both abnormalities can be ascribed to altered function of the insulin signaling pathway. Over the last five years, the PI's laboratory has endeavored to meet the following goals: i, to define the contribution of different insulin target tissues to the integrated pathophysiology of insulin resistance; ii, to examine the contribution of branching Insulin Receptor (InsR) signaling pathways to different aspects of this process in vivo; and iii, to integrate the pathogenesis of insulin resistance with that of β cell failure. These studies have upended the notion that insulin resistance in muscle and fat is sufficient to cause diabetes, by emphasizing that non-canonical sites of insulin action, such as CNS and endocrine pancreas, play an early and decisive role, along with the liver, in the progression from insulin resistance to diabetes. Work supported by this grant has also contributed to establishing the idea that pancreatic β cells are an "insulin-sensitive" cell type. Building on these lessons, the PI proposes studies of the integrated physiology of insulin action that will focus primarily on the contribution of CNS, liver and enteroendocrine system to the insulin-resistant state. The PI presents extensive preliminary data putatively identifying an "insulin-sensitive" neuron population, characterized by Glut4 expression; as well as a novel gut epithelial progenitor cell, characterized by Foxo1 expression, having the unique ability to give rise to bona fide insulin-secreting, "β-like" endocrine cells. Both cell types have the potential to regulate insulin action, and the PI proposes genetic and cell biology experiments to understand their relative contributions to peripheral insulin sensitivity and β cell function. The mainstay of the proposal continues to be the use of targeted mutagenesis to interrogate genes of interest, followed by extensive phenotyping to analyze their consequences. Three aims are outlined: Aim 1. Studies of the past cycle have established that conditional knockout of InsR in muscle, fat, and Glut4-expressing CNS neurons is sufficient to cause diabetes, unlike the combined knockout of InsR in muscle and fat. Buoyed by this exciting observation, the PI's laboratory will analyze the role of Glut4-expressing neurons in metabolism, with an emphasis on their contribution to CNS glucose sensing, counterregulation and endocrine islet/brain communication. Moreover, the development of unique reporter mice to label Glut4-expressing neurons with unprecedented sensitivity and selectivity throws open the possibility to examine their lineage and in vivo regulation, and to isolate them in the culture dish, in order to learn their cellular biological and neural transmission properties. Aim 2 will delve into the pathophysiology of hepatic insulin resistance, and specifically into the identification of transcription factors that cause the paradoxical admixture of increased hepatic glucose production (HGP) and increased triglyceride (TG) synthesis that characterizes the diabetic liver. Having established a role for the forkhead protein Foxo1 in HGP, the PI will tackle the question of whether aberrant Foxo1 activity can lead to an 'encroachment' of this transcription factor on the Srebp-1c pathway and promote hepatic lipid accumulation, setting the stage for hepatic insulin resistance. Using a novel 'knock-in' mouse model, the PI will explore the possibility that Foxo1 affects hepatic lipid production through its co-regulatory functions, i.e., acting in a DNA binding-independent fashion. Aim 3 will study the role of insulin signaling in gut enteroendocrine progenitor cells. The PI's laboratory identified a sub-population of gut epithelial progenitor cells that express the insulin-regulated transcription factor Foxo1. Surprisingly, when Foxo1 is genetically ablated from these cells, they are reprogrammed to give rise in vivo to insulin-positive, "β-like" cells that secrete insulin in response to glucose. The PI proposes a series of genetic manipulations to understand Foxo1's physiologic role in Neurogenin3 (Neurog3)-positive enteroendocrine progenitors, as well as their reprogramming capabilities and mechanisms, with an eye to exploiting them for "therapeutic" purposes, by way of novel techniques for gut-directed RNAi delivery. In addition, the PI describes studies in isolated gut-derived, insulin- producing cells to better characterize their cell biology and potential uses. The proposed body of work will advance our understanding of the insulin-resistant syndrome at the biochemical, genetic, and integrated physiological levels, with the ultimate goal of translating newly acquired information into innovative approaches to its treatment. 1 Genes are in italics, gene products in regular font. CNS: central nervous system; Glut4: glucose transporter 4 (encoded by Slc2a4); Glut3: glucose transporter 3 (encoded by Slc2a3); InsR: Insulin receptor; Igf1R: type 1 IGF receptor; Irs: InsR substrate; Fox: forkhead box-containing transcription factor; Gck: Glucokinase; Pomc: proopiomelanocortin; AgRP: Agouti- related protein; Glut4 neuron: Glut4-expressing neuron; HGP, hepatic glucose production; TG: triglyceride; HFD: high-fat diet (60% fat); Neurog3: Neurogenin-3; 2-DOG: 2-deoxyglucose; ICV: intracerebroventricular.